Advancing Native American Diversity in Aging Research through Undergraduate Education (Native American ADAR)

PROJECT SUMMARY
This application, responsive to PAR-17-290, seeks R25 funding for “Advancing Native
American Diversity in Aging Research through Undergraduate Education.” By offering
annual courses and mentored research—along with online virtual education and mentoring during
this COVID-19 pandemic—we recruit students from Native American backgrounds, both urban
and non-urban, to encourage them to pursue careers investigating Alzheimer’s disease and
related dementias (ADRD) and aging mechanisms, and help to launch their scientific careers.
The ADRD and aging fields continue to grow swiftly, as does the elderly population, yet there are
too few laboratories led by under-represented minority (URM) scientists, let alone Native
American PIs, and too few new URM trainees. This R25 is directed by Gerald Schatten, PhD
(Pitt), and Laura Niedernhofer, MD, PhD (Minnesota), who join David Burgess, PhD (Cherokee,
Boston College); Melissa Wells, PhD (Bois Forte & Couchiching First Nation Anishinaabe, Johns
Hopkins - Duluth); Paul Robbins, PhD (Minnesota); and Calvin Simerly, PhD (Pitt) as the
Executive Committee. The course is held at Minnesota’s Institute on the Biology of Aging and
Metabolism, directed by Laura Niedernhofer, MD, PhD, and Paul Robbins, PhD. Daily lectures,
active learning, and extended discussions on emerging concepts, followed by lab and group
exercises and informal seminars are held over a week (August 15-21, 2021). Both hands-on and
online training for 16 participants on recent discoveries regarding ADRD’s root causes and
treatments is presented, with special attention devoted to Native Americans; the biology of aging
is also considered. Frequent interactions are maintained with each trainee afterwards, to evaluate
the course and provide ongoing mentoring. Conducted with sensitivity to tribal histories, five
specific aims are proposed: I. Provide conceptual education and research training in ADRD and
the Biology of Aging, with relevance for Native American trainees; II. Support mentored pilot
research, especially involving challenges in health disparities and diversity related to Native
Americans; III. Encourage trainees’ and alumni’s longer-term career planning through personal
coaching, mentoring sessions, and peer-to-peer advice; IV. Discuss NIH regulatory requirements
within the context of Tribal Sovereignty; and V. Evaluate, improve, and monitor the Native
American ADAR’s strengths and avoid weaknesses with unbiased, quantitative, independent
mechanisms which track trainees’ and alumni’s achievements to ensure that the program is a
wise, cost-effective investment. In so doing, we will enhance and expand the research careers of
promising trainees, especially Native Americans, to help ensure full diversity in the NIA and NIH.

Public health relevance
PROJECT NARRATIVE We seek funding for our new program, Advancing Native American Diversity in Aging Research through Undergraduate Education, within the NIA’s ADAR R25 program (PAR-17-290). This week-long annually offered class concentrates on recruiting undergraduates, especially from Native American backgrounds, and offers exciting and relevant opportunities for training, including virtual options in response to the COVID-19 pandemic, with the goal of launching research careers in the investigation of Alzheimer’s disease and related dementias and the biology of aging. This is achieved through scientific education, mentored projects, and retention of the participants in the NIH research workforce via ongoing career counseling and personal advice, along with annual updates and refresher programs.